BIOMOLECULAR CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The mission of the Biomolecular Core Laboratory is to support research and discovery by improving access to, and stimulating the use of, emerging technologies by researchers, clinicians and students. For enhanced leveraging of regional resources, the BCL is integrated with other core labs in the Delaware Valley through the IDeA Network for Biomedical Research Excellence (INBRE) network.